Molecular regulation of skeletal muscle thermogenesis

Abstract
The induction of obesity results from an increase in energy storage relative to energy expenditure and until
a new energy equilibrium is established at higher pathophysiologic weight. Obesity is increasing at an alarming
rate in the USA with approximately one-third of adults and one-fifth of children classified as obese. In addition,
to the direct health care costs, work loss and morbidly, obesity is the primary factor driving insulin resistance
and type 2 diabetes. At the experimental level over the past decade there has been a substantial effort focused
on increasing energy expenditure through the development/activation of brown/beige adipose tissue
thermogenesis. In contrast to adipose tissue, collectively skeletal muscle accounts for approximately 50% of
body mass, is the primary determinant of basal metabolic rate and is the major driver of increased energy
expenditure that occurs during physical activity. In addition, involuntary skeletal muscle contractions or
voluntary activity based skeletal muscle contractions accounts for the majority of heat production during cold
induced thermogenesis that can reach 15-20 times the resting basal metabolic rate.
During our phenotypic characterization of the TIGAR knockout mice, to our surprise these mice display a
remarkable cold resistant phenotype that is independent of brown and beige adipocyte function and is a result
of increased skeletal muscle thermogenesis. We plan to use mouse genetics, metabolic profiling and
physiologic assessments to determine the molecular basis for the cold resistance that occurs due to TIGAR
deficiency. The specific novel aspects of our current findings are that: i) TIGAR deficiency does not affect
energy production at room temperature but markedly enhances cold induced thermogenesis, ii) the increased
thermogenic response is due to a direct activation of skeletal muscle ATP turnover through increased
contractile activity and iii) the increased skeletal muscle contractile activity results from TIGAR deficiency in
cholinergic neurons at the neuromuscular junction. A schematic representation of the mechanism(s)
responsible for cold resistance in TIGAR knockout mice is illustrated and described in Figure 1. The specific
novel aspects of the proposed research plan are: 1) to genetically determine whether TIGAR deficiency
enhances skeletal muscle contraction based thermogenesis through increased cholinergic tone, 2) to
determine whether the enhanced activation of skeletal muscle thermogenesis results from a loss of
TIGAR protein dependent binding interaction(s) and/or due to a loss of TIGAR phosphatase activity, 3)
to map the resultant changes in metabolic flux that occurs between thermoneutrality, room
temperature and cold exposure in skeletal muscle, and 4) to identify the novel TIGAR-dependent
molecular pathway responsible for the increase in cholinergic neuron signaling.

Public health relevance
Narrative: The long-term regulation of body mass and adiposity is dependent upon the balance of energy intake and energy expenditure. During the development of obesity, energy intact is greater than expenditure resulting in increased adiposity until a new steady-state balance is achieved. Current therapies to reduce weight such as diet decrease energy intake but for a variety of physiologic reasons has not proven successful. However, increasing energy expenditure is a potential viable option but current studies have primarily focused on brown and beige adipocyte activation. We have uncovered a role for a metabolic enzyme termed TIGAR that functions at the neuromuscular junction to regulate skeletal muscle contraction and heat production through the induction of increased cholinergic tone.